Core 1: Administrative Core

Core 1: Administrative Core Abstract The Administrative Core will provide the administrative structure, oversight, and logistical support for the entire Team BCP effort, with the goal of creating synergy among member labs, cores, and projects to best facilitate the proposed research. The Administrative Core includes support for the annual visits of the External Advisory Board to Caltech, travel for the off-site member of the team to attend all Advisory Board Meetings, and maintenance of a website dedicated to the Team BCP. This Core will also coordinate with both the Data Science Resource Core and the Instrumentation and Software Resource Core to ensure equitable distribution of resources to all member laboratories. The Lead PI of this Core, Dr. Michael Dickinson, together with an administrative staff, will provide logistical support for the project. These tasks range from fiscal oversight, to scheduling meetings with member PIs at other institutions, to coordination of efforts with the other project cores. Working with all member PIs, the Administrative Core will be responsible for recruiting an external scientific advisory board and running an annual meeting to be held at Caltech. The Core will arrange travel, accommodations, and logistics. This Core will ensure the dissemination of all products related to the research, including prompt filing of progress reports, ensuring all publications are uploaded to PubMed, and other related administrative and communications functions including maintenance of the program website. In the case of press coverage of any research resulting from the program, we will work with all PIs and the laboratories to ensure that NIH is acknowledged in an appropriate manner.